Selective packaging and protection of HIV-1 genomic RNAs

Abstract
Virtually every step of HIV-1 replication as well as numerous cellular antiviral defense mechanisms are
regulated by viral and cellular RNA-binding proteins (RBPs) that recognize distinct sequence or structural
features on viral RNAs. One such interaction takes place between the HIV-1 major structural protein, Gag, and
the viral genomic RNA (gRNA). Through its nucleocapsid (NC) domain, Gag selects two copies of an unspliced
positive strand gRNA from a pool of cellular and spliced viral mRNAs in excess and orchestrates key steps of
virion assembly. How gRNAs are selected for packaging, why only a dimer is packaged in a single virus particle
and whether NC-gRNA interactions guide other RBPs that target the same gRNA remain poorly understood.
Previous CLIP studies demonstrated that Gag predominantly binds to guanosine-rich sequences in the
cytosol, but its binding preference shifts towards sequences with adenosine-rich nucleotide composition
(including binding sites on cellular mRNAs) at the plasma membrane where virions assemble. Here we propose
to formally test whether adenosine-richness of the HIV-1 gRNA facilitates its selective packaging through
complementary genetic and biochemical approaches (Aim 1). According to a widely accepted model, recruitment
of a dimeric gRNA to the plasma membrane nucleates virion assembly, resulting in progressive recruitment of
Gag molecules from the cytosol. As the late arriving pool of Gag molecules at the nucleation site needs to be
devoid of RNAs, we hypothesize that affinity of Gag towards cognate RNAs is a key parameter that underpins
dimeric gRNA packaging. In Aim 2, we propose to disrupt this balance by generating Gag chimeras with altered
affinity/avidity towards target RNAs and determine the impact on dimeric gRNA trafficking to the PM, gRNA
packaging and virus particle assembly. In Aim 3, using the Gag chimeric viruses as tools, we propose to target
key NC functions and determine the NC- and gRNA-dependence of other viral and host RBPs that are critical
regulators of HIV-1 replication and host defenses. Specifically, we propose to examine whether members of the
antiviral APOBEC3 protein family infiltrate into virions through binding to the viral gRNA or other virion-
incorporated host RNAs, such as 7SL. As part of this aim, Gag chimeras that can package gRNA independent
of NC will be used to test the dependence of integrase-gRNA binding, an event critical for proper virion
maturation, on NC and NC-gRNA interactions.
Understanding the interplay between multiple RBPs that target the same gRNA is highly relevant to our
fundamental understanding of HIV-1 replication and virus-host interactions. Currently, no antiretrovirals target
gRNA packaging and assembly despite these steps presenting a clear vulnerability for HIV-1. Our preliminary
studies demonstrate that Gag-gRNA interactions are finely tuned and can be targeted. Proposed work is thus
significant as it may guide the development of NC- or gRNA-targeted drugs that abrogate gRNA packaging,
virion assembly and infectivity.

Public health relevance
Project Narrative Nearly every step of HIV-1 replication is regulated by a dynamic set of interactions between viral and cellular RNA binding proteins and viral RNAs. In this application, we propose to identify new rules by which HIV-1 selectively packages its RNA genome and why it preferentially packages a dimeric genome. We will also define the interdependence of NC-gRNA interactions with other viral and host RNA-binding proteins that bind to the same gRNA at different phases of virus replication.